Diversity Suppplement (CIRCADIAN) Circadian Disruption as Mediator of Cardiometabolic Risk in Air Pollution

Particulate matter air pollution <2.5µm (PM2.5) is the leading environmental risk factor globally,
contributing more to global mortality than AIDS, malaria, tuberculosis and wars/famines combined.
The health risks associated with PM2.5 are predominantly from cardiovascular (CV) causes, with data
supporting a major public health impact due to disorders such as type 2 diabetes. Building on the
substantial successes of our research program, that in large part have provided the foundational
basis for our understanding of mechanisms of PM2.5-induced cardiometabolic disorders, we propose
an innovative framework of translational investigations. Our new data provide compelling links
between PM2.5 exposure and circadian rhythm (CR) disruption through epigenetic reprogramming,
resulting in metabolic dysfunction and insulin resistance. In accordance with the NIEHS Translational
Research Framework, we propose an ambitious plan encompassing 3 goals over 8 years that will
encompass harmonized studies involving concentrated ambient PM2.5 exposures (animal) and human
intervention trials across the ambient exposure spectrum, predicated and supported by results from
genome wide association and mendelian randomization approaches, that will identify pathways of air
pollution mediated CV risk. Leveraging on-going translational clinical trials of air pollution reduction
using personalized strategies in vulnerable populations in Beijing, and through one new study
involving mitigation of air pollution (ITS-MY-AIR), we will evaluate the impact of exposure reduction
on CR disruption/sleep and metabolic endpoints. Collectively, results from this project will help shed
important new light on air pollution, its impact on CR and cardiometabolic disorders and provide
influential data on protective effects of personal intervention strategies, that together could change
public health policy.

Public health relevance
Air pollution is the world’s most important environmental risk factor that contributes more to global morbidity and mortality than tuberculosis, malaria, AIDS, wars and famine combined. In this transformative project, we provide compelling new data on air pollution as a disruptor of endogenous biologic “circadian” rhythms. Through careful studies in animals and humans and large cohorts, we will evaluate the impact of exposure and personalized interventions on heart and metabolic health. Our results will provide compelling new data to prevent the health problems caused by air pollution exposure globally.